Palliative Care for People Living at Home with Advancing Dementia and Their Caregivers

Project Summary/Abstract
This is an application for a K01 award for Krista Lyn Harrison, PhD, whose research focuses on improving
life for older adults with Alzheimer’s disease and related dementias (ADRD) and their informal caregivers. Dr.
Harrison is a health services and policy researcher and Assistant Professor in the Division of Geriatrics at the
University of California, San Francisco (UCSF). Dr. Harrison has 12-years of experience in qualitative methods
and led the research enterprise of a large hospice prior to completing a UCSF aging research fellowship and
implementation science certificate. Through the activities proposed in this application, Dr. Harrison will
strengthen and address gaps in her experience through a training plan focused on: a) advanced statistical
methods in linked datasets, b) ADRD clinical care and research, and c) translating mixed-methods data into
ADRD interventions. Resources to foster her career development include UCSF’s nationally-recognized
Division of Geriatrics, Memory and Aging Center, Institute for Health Policy Studies, and K Scholar’s program,
Dr. Harrison has assembled an extraordinary multidisciplinary team with extensive expertise.
Alzheimer’s disease and related dementias are progressive incurable illnesses causing significant public
health burden. Palliative care focuses on reducing suffering and improving quality of life by attending to the
multi-dimensional sources of distress for seriously ill individuals and families. Evidence for quality palliative
care for advanced ADRD comes primarily from research in nursing homes. For the more than 700,000 older
adults with advanced Alzheimer’s disease who die at home each year, clinicians lack population-level evidence
to guide caregivers and patients in anticipating and planning for disease changes. The proposed K01 will
address critical knowledge gaps and develop a toolkit of resources to support basic palliative care provided by
neurologists. Dr. Harrison will first use a nationally-representative dataset to longitudinally examine factors
associated with mortality and nursing home stay among people living at home with severe and advancing
ADRD. Second, she will use semi-structured interviews with older adults living at home with ADRD, current
and bereaved caregivers to understand palliative and end-of-life experiences and opportunities to improve
palliative care for ADRD. Third, Dr. Harrison will work with multiple stakeholders to refine and assess the
feasibility of a toolkit of basic palliative care resources for use in neurology clinical practice (such as an
assessment checklist, evidence-based strategies for discussing serious illness prognosis and advance care
planning adapted for ADRD, referral and billing guides, and summarized evidence from Aims 1 and 2 on living
at home with ADRD to inform anticipatory guidance). The goal of this toolkit is to improve neurologists’
communication with older adults living at home with advancing ADRD and/or their informal caregivers. The
proposed research will provide Dr. Harrison with the preliminary data, training, and experience to support
future competitive independent R-series applications to test the efficacy and effectiveness of her intervention.

Public health relevance
PROJECT NARRATIVE Dementia is a progressive, incurable serious illness causing significant public health burden. Neurologists increasingly recognize that palliative care, an approach to care designed to reduce suffering and improve quality of life, could meaningfully help people with dementia and their informal caregivers, particularly when deployed early on. The proposed study will utilize multiple types of data to understand the needs of older adults living at home with advancing dementia and their caregivers and then use that information to develop and refine a toolkit (with input from people with dementia, caregivers, and clinicians) to enable neurologists to assess and address basic palliative care needs this population.